CORE B: CAREER ENHANCEMENT

PROJECT SUMMARY/ABSTRACT
The Career Enhancement Core will continue and expand our current efforts to build the community of
investigators with the knowledge, skills and experience to conduct high quality cutting edge tobacco regulatory
science. The Core has three interrelated parts: the TCORS Fellowship, Developmental Pilot Projects, and a
Researcher/Faculty Exchange Program. Each part is built on the foundation of UCSF's currently funded
TCORS and the well-established fellowship program of the UCSF Center for Tobacco Control Research and
Education. Because the Career Enhancement Core uses existing infrastructure almost all funds will directly
support researcher salaries, research, and collaborative activities. The Core will achieve three specific aims:
(1) Enhance career development in tobacco regulatory science expertise among students, fellows, new and
early stage investigators, and established investigators who are new to tobacco regulatory science; (2)
Administer the selection of and supervise the implementation of Developmental Pilot Projects in tobacco
regulatory science; and (3) Facilitate collaborative career enhancing networking opportunities through a
researcher/faculty exchange program connecting UCSF TCORS investigators with investigators from other
TCORS. The TCORS Fellowship provides salary support for two postdoctoral fellows with interest in
conducting tobacco regulatory science, and offers them opportunities to pursue supervised research projects,
a specialized curriculum that includes all the FDA Scientific Domains relevant to tobacco regulatory science
(health effects, behavior, communications, marketing influences, toxicity, addiction, and impact analysis), pilot
project funds, and travel funds for TCORS meetings and other conferences. The Developmental Pilot
Projects support 2-3 studies of $50,000 each in tobacco regulatory science annually, and funds are available
to any UCSF postdoctoral fellow or faculty member in order to encourage interest in tobacco regulatory
science. The peer review process for these pilot studies utilizes the UCSF Research Allocation Program, which
is a campus-wide program that coordinates intramural funding reviews modeled on NIH study sections. The
Researcher/Faculty Exchange Program provides support for formal and informal opportunities for travel and
presentations at other TCORS and other relevant career-building experiences (e.g., visits to FDA), and to host
visitors from other TCORS to participate in Fellows' meetings or research retreats. We have established
productive working relationships with investigators the other TCORS, we are active in several cross-TCORS
working groups in measurement, training and communication, and our faculty serve on the advisory
committees for several other TCORS. We will continue to contribute shared resources, didactics and curricula
to all the other TCORS in order to continue developing the community of investigators in tobacco regulatory
science.